Medical Scientist Training Program at the University of Nebraska

Project summary/abstract
The MD-PhD program at the University of Nebraska Medical Center (UNMC) trains physician
scientists to improve health and reduce health disparities. Through doubling the program size
since 2007, increasing NIH-funded F30/F31 fellowship awards from 2 to 16, maintaining time-to-
degree that is better than the national average, improving anatomy test scores over 20
percentage points, and holding attrition below 10%, we have documented training success.
Over a third of our trainees earn extramural fellowships (44%) and most hold student leadership
roles. UNMC is ranked in the top 10 nationally for primary care training and rural practice and
has research strengths in cancer biology, infection and inflammation, neuroscience,
cardiovascular disease, and aging. The program curriculum provides career development that
fosters critical thinking, adult learning, challenging paradigms, and using data to inform research
and care. We foster a positive and inclusive culture of training for students and focus on trainee
well-being and professional activities. The program objectives are: (1) Recruit diverse trainees
committed to advance biomedical research; (2) Integrate medical and research training; (3)
Promote productivity of students in advanced research areas; (4) Develop a cohort of mentors
who promote student development; (5) Support service learning, community care, and
development of clinical skills; (6) Develop student transferable and leadership skills through
principles and practice; (7) Maintain appropriate time-to-degree for student success; and (8)
Foster retention by preparing students to overcome potential barriers. We have applicants from
42 states and 20% of our applicants and trainees (plus 37% of program faculty) have rural
backgrounds—compared to only 6% of MD applicants nationally. Our directed efforts over the
last 15 years increased recruitment and representation of women trainees and brought the
percent of women trainees from less than 6% to 55%. Nebraska is an IDeA state with
infrastructure for clinical and translational research faculty through the Great Plains IDeA CTR
and the Nebraska Pediatric Clinical Trials Unit. In this proposal, we propose the Nebraska
Leading Equity and Diversity MSTP to support physician scientist training and request two
funded training slots in the first year, 4 slots in year 2, and six per year after that. In this funding
period, we will increase assessment sophistication, enhance alumni engagement, build our
mentorship training, increase recruitment of scientists underrepresented in medicine, and
provide leadership skills to all trainees. We will leverage the requested T32 funding to advance
our program and change medicine.

Public health relevance
Narrative UNMC researchers are leaders in cancer, infection and inflammation, neuroscience, cardiovascular disease, and aging. Clinical expertise abounds with national recognition for primary care training, rural practice, and handling the toughest infectious diseases. In this proposal, our MD-PhD program seeks to create the Nebraska LEAD MSTP to train diverse, curious, and caring students to become physician scientists equipped with the clinical and research tools to change medicine.